Cerebral Substrate Support After Traumatic Brain Injury

Project Summary/Abstract
Basic science and clinical research has shown that traumatic brain injury (TBI) results in immediate and
transient increases in glucose uptake (CMRglc) to re-establish ionic equilibrium and neurochemical
imbalances. This is rapidly followed by a prolonged period of glucose metabolic depression, a hallmark
of TBI and a critical component of the cerebral metabolic crisis. During this depression the brain is
vulnerable and there are many problems with glucose metabolism. We have shown that early
administration of alternative substrates after injury reduces cell loss, improves cellular energy and early
beahvioral outcomes. This grant will directly compare the capacity of alternative substrates to
decrease metabolic crisis, improve mitochondrial energy, decrease free radical damage and improve
long-term function in both male and female subjects. Findings from these studies will establish which
brain fuels are optimal for recovery in both genders after TBI.

Public health relevance
Project Narrative Our previous research has characterized a state of brain metabolic crisis after traumatic brain injury and has shown the therapeutic benefits of providing alternative fuels for the brain. This grant will conduct a head to head comparison of different fuels shown to be neuroprotective after head injury, to determine the optimal dose and delivery paradigms to improve brain energy production and improve long-term functional outcome after traumatic brain injury in both male and female brains.